Establishing Targets for Precision Prevention of ADRD in American Indians

Modified Project Summary/Abstract Section

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.

Alzheimer’s disease and related dementias (ADRD) are a leading cause of death with substantial economic and human costs. Despite advancements in anti-amyloid therapies the most effective approach to reduce ADRD is through primary prevention. Up to 40% of the global burden of dementia is attributed to modifiable (i.e., non-genetic) factors, though few studies have examined the effect of these prevention targets in American Indian populations. The proposed study seeks to address this gap by identifying lifecourse factors and the timing of these factors among American Indians to inform precision prevention of ADRD for this population. Specifically, this study will employ advanced epidemiology methods to triangulate data leveraged from large samples of American Indians in two publicly available surveillance datasets (BRFSS, and the NHIS) with findings from two NIH-funded longitudinal cohorts of American Indian Elders: The Strong Heart Study (R01HL093086, PI: Buchwald) and the Urbane Study (R01AG064493, PI: Nelson). This research is an important next step for the Research Project Lead’s career development toward a long-term career goal of conducting impactful research that promotes healthy cognitive and brain aging in American Indians and other rural Mountain West populations.